Determining the Role of Glucose Transporter 1 in Neural Development and Disease

PROJECT SUMMARY
Glucose homeostasis is critical during embryogenesis; fetal hyper- or hypoglycemia can cause
neurodevelopmental disorders, including impaired neurulation, altered brain growth, epilepsy, Autism, and
Attention Deficit Disorder. GLUT1-Deficiency Syndrome (GLUT1-DS) causes a variety of neurological disorders,
including infantile seizures, developmental delay, postnatal microcephaly, and intellectual disability. To better
understand the role of Glut1 during cortical development and the contribution of neural progenitor cell (NPC)-
specific GLUT1 loss to GLUT1-DS, we aim to determine how NPCs regulate glucose uptake during neurogenesis
and how glucose metabolism influences NPC self-renewal and cell fate decisions. Our preliminary data make
us hypothesize that 1) Glut1 expression in cortical NPCs (termed radial glia; RG) regulates glucose uptake and
metabolism dynamics throughout neurogenesis to direct cell fate decisions. 2) During human development, early
changes in RG proliferation due to a reduction in GLUT1 expression impact neurogenesis and contribute to the
etiology of GLUT1-DS. To test these hypotheses, we will pursue two parallel aims in mouse and human models
of cortical development. Aim 1 will explore the function of Glut1 in RG during mouse corticogenesis. We will
conditionally remove Glut1 from RG and determine the impact on proliferation, cell cycle dynamics and
differentiation using a combination of approaches including immunohistochemistry, single cell transcriptomics,
and fluorescent in situ hybridization. We will assess the metabolomic changes associated with loss of Glut1
through metabolic flux and proteomic assays. Aim 2 will use cerebral organoids generated from human
pluripotent stem cells harboring GLUT1 mutations and examine the impact on cortical differentiation and
neuronal function. Using a cerebral organoid model will enable us to explore the neural contribution to GLUT1-
DS and potential evolutionary differences between progenitor metabolism in mouse and humans. Experiments
will combine cutting edge technologies to determine the link between RG metabolism and cell fate decisions
using in vivo and in vitro metabolomic assays along with single-cell transcriptomic and imaging methods.
Pursuing these aims will open new avenues of inquiry into the metabolic regulation of RG fate and differentiation
in health and disease. Our long-term objective is to understand the combinatorial actions of environmental and
genetic factors during cortical development and identify potential therapeutic pathways.

Public health relevance
PROJECT NARRATIVE. Understanding the role environmental factors in the temporal regulation of NSCs is critical to our understanding of brain development and the etiology of neurodevelopmental disorders. The proposed studies seek to investigate the genetic mechanisms through which NSCs regulate glucose uptake and metabolism in order to control cell fate decisions. Through these studies we will gain novel insights into the mechanisms that underpin the relationship between glucose homeostasis and neurodevelopmental disorders, including GLUT1-Deficiency Syndrome.